DIP13alpha and DIP13beta Phosphoinositide Binding

[unreadable] DESCRIPTION (provided by applicant): [unreadable] [unreadable] Interactions between proteins and phosphoinositides can affect subcellular localization, protein-protein interactions, enzymatic activity, and downstream signaling events in a spatially and temporally controlled manner. Intracellular phosphoinositide levels are tightly controlled by specific kinases and phosphatases, and the importance of this regulation is reflected by their association with several human diseases, including cancer, acute myeloid leukemia, diabetes, X-linked myotubular myopathy, Charcot-Marie-Tooth disease, and Lowe syndrome. The focus of this project is to determine the functional role of pleckstrin homology domain-mediated phosphoinositide binding of human DIP13( and DIP13(, which are involved in G2/M cell cycle regulation, modulation of AKT activity, and apoptosis. The first aim is to determine phosphoinositide binding specificity and affinity. The second aim is to identify membrane-associated subcellular localization of DIP13( and DIP13(. The third aim is to determine whether phosphoinositide binding contributes to known DIP13( and DIP13 functions. The final aim tests the hypothesis that homo-oligomerization facilitates phosphoinositide binding. It is hoped that these studies will lead to an independent research program. [unreadable] [unreadable] [unreadable]